Improving Access and Automating Fitting for Hearing Aid Devices for the Underserved and Rural Populations

Abstract
This proposal responds directly to the purpose of the RFA-MD-22-003 STTR Funding Opportunity
Announcement (FOA). Nearly 44 million Americans experience hearing loss, but as much as 86% of adults
who could benefit from hearing aid devices (HAD) do not use them. Untreated hearing loss is almost twice
more prevalent in rural areas. More than 46 million people live in rural America, but these communities face
significant barriers and delays in accessing care and experience a lack of providers for audiology services. The
average retail price of HADs was $4,700, making it prohibitively expensive the rural and minority populations
who have lower incomes. Hearing loss is also highly prevalent in black and Latino/Hispanic communities and
growing, but older black adults were 58% and Mexican American older adults were 78% less likely to use
HADs, due to reasons of high cost and lack of insurance coverage. Aside from cost, concerns about comfort,
effectiveness and satisfaction are the other significant barriers to HAD usage.
A long-term goal of hearing health professionals, the auditory research community, and HAD makers has
been to reduce these barriers. The current hearing care delivery in the U.S. follows a model of specialty clinic-
based care, through audiologists, which is costly and time-consuming for the rural and minority populations.
The introduction of over-the-counter (OTC) HADs is set to disrupt this model and increase accessibility and
affordability of hearing care for these populations. Automation of HAD fittings and self-adjustments further
enable listeners to pick gain settings according to their individual preferences, which significantly increases
listener satisfaction and acceptance. It is common practice today for an audiologist to follow a time-consuming
process in which she fine tunes the HAD settings to the users’ individual demands, based on verbal
descriptions from the user. This approach is burdensome to both the audiologist and the HAD user and might
not provide the satisfaction and comfort the user truly desires. Allowing users to make these changes easily via
automation can vastly improve their satisfaction and use of HADs.
This project will develop machine learning (ML) based automatic gain adjustment software in a
smartphone with a Graphical User Interface (GUI), to minimize the effort required for individualized settings in
an OTC HAD. Recent studies of self-adjusted gain have shown consistent within-subject preferences but gain
settings that differ greatly from prescribed settings (up to 20dB), and also shown a great deal of between-
subject variability in gain preferences. We propose a Deep Neural Network (DNN) based prediction model that
learns the non-linear relationships in the data and outcomes, otherwise difficult to ascertain through normal
statistics. The DNN will be combined with other ML techniques to refine the final gain settings. With
smartphone assistive software and the predictive power of ML, our proposed solution will automate
personalized fittings for OTC HADs, significantly improving their accessibility, affordability and acceptance,
thus benefitting the rural and minority populations the most.
Automating HAD gain settings with the use of machine learning (ML) techniques will increase the ease of
use and reduce costs while improving intelligibility and comfort. OTC HADs will improve access and cost and
will lead to much higher adoptions of HADs in the rural and minority communities, improving their quality of life.

Public health relevance
Project Narrative Nearly 44 million Americans experience some hearing loss, but as much as 86% of adults who could benefit from hearing aid devices (HAD) do not use them. HAD usage is disproportionately lower among rural and minority (black, Hispanic/Latino) populations. Concerns about access, cost, comfort, effectiveness and satisfaction are key barriers to HAD usage. Self-adjustment enables users to pick HAD gain (amplification) settings according to the users’ widely varying individual preferences, which has been shown to significantly increase listener satisfaction and acceptance. Automating HAD gain settings with the use of machine learning (ML) techniques will reduce costs while improving intelligibility, comfort and increase the ease of use. As OTC HADs become available, this will lead to much higher adoptions of HADs in the rural and minority communities, improving their quality of life.